BLRD Research Career Scientist Award Application

Project Summary/Abstract
Dr. Richards (Phillips) directs a research group within her laboratory, comprising a Senior Research Associate,
full-time laboratory technicians, a graduate student, and several summer interns. She also directs the
NIH/NIAAA-funded Portland Alcohol Research Center (PARC), which involves 14 research scientists and their
laboratory research personnel. The PARC is working toward the common goal of investigating the role of the
tetrapartite synapse, with components including the pre- and post-synaptic neuron, astroglial processes, and
the extracellular matrix (ECM), in risk for and the impact of chronic alcohol drinking. She has a research
component in the PARC and funded grants supporting methamphetamine (MA) research. Overall, her
laboratory develops and utilizes specialized genetic mouse populations, with the goal of understanding
multifaceted etiologies of risk for addiction and of identifying personalized treatments. The genetic mouse
populations model various aspects of addiction and are then subjected to in-depth study of the transcriptome,
single gene effects, genetically correlated behaviors and neural mechanisms. She studies multiple sensitivity
factors, including drug stimulant effects, reward, reinforcement, aversion, avoidance, cognitive factors, and
physiological correlates. Most recently, her work has placed a particular emphasis on resilient individuals with
strong genetic risk that do not choose high levels of drug intake. She believes that study of these individuals
will provide important information about opposing genes and mechanisms relevant to therapeutic development.
These protective effects are understudied in comparison to use-promoting rewarding drug effects. In fact,
human genetic studies do not include individuals who have experimented with a drug and found it to be
aversive, therefore avoiding its use. Nor have they delved into individual differences as much as population
effects (i.e., common is comparison of non-users and groups with use disorders). Dr. Richards' VA Merit
Review-funded research is focused on binge MA use and the impact of a single nucleotide polymorphism in
the trace amine-associated receptor 1 gene (Taar1m1J), discovered by her lab to account for 60% of the genetic
variance in voluntary MA intake in her selected line genetic animal model. Aims include identifying neurotoxic
effects of MA and the role of Taar1 variation in sensitivity to those effects; and identification of genetic
modifiers of the high risk, Taar1m1J/m1J genotype that predicts high levels of voluntary MA intake, using selective
breeding and transcriptomics. Her funded R01 grant was used to generate knock-in mice to prove that Taar1 is
a quantitative trait gene for MA intake and other MA traits that impact MA intake, including traits that index
sensitivity to MA reward and aversion. Recombinant inbred strains are being used to compare gene network
outcomes in mice that all possess the high risk Taar1m1J/m1J genotype, but exhibit different amounts of MA
intake. Targeted assessment of a potential interactive effect of the mu-opioid receptor gene (Oprm1) indicate
that Oprm1 allelic variation impacts the effect of Taar1 genotype on MA intake and other MA-related traits. Dr.
Richards' research project within the PARC is studying the risk transcriptome for alcohol preference using mice
selectively bred for high or low alcohol preference. She is also performing research designed to dissect
transcriptional differences associated with individual variation in response to genetic risk, by examining gene
expression networks in mice with differential levels of preference from the high alcohol preference line. Finally,
her research group is performing treatment-related research based on transcriptome findings, exploring new
pharmacotherapeutic avenues for alcohol use disorder.

Public health relevance
Project Narrative Dr. Richards' research examines genetic factors that influence not only population risk, but individual risk, for the unhealthy use of alcohol, methamphetamine and other drugs, including opioids. In 2012, the US National Drug Control Strategy identified active military personnel, Veterans, and their families as populations requiring special support to deal with their drug use problems. In 2022, the same publication reported that the VA is the first organization to implement an evidence-based contingency management “incentives” intervention on a wide-scale that has shown some efficacy. Considerable evidence suggests that mental health disorders are best served by combining psychological and pharmacological interventions. Dr. Richards' research program focuses on genetic and genomic factors that impact initial and continued substance use, as well as the consequences of use. A major goal is to identify individual risk and response mechanisms that could lead to personalized medical advances for addiction and greatly benefit Veteran's health.